BIOTRANSFORMATION OF THE ANTICANCER AGENT BETULINIC ACID

DESCRIPTION: The main goal of the project is to study the mammalian metabolism of the anticancer agent betulinic acid using microorganisms as in vitro models of mammalian metabolism. Microorganisms, particularly fungi, have been utilized successfully in studying the mammalian biotransformations of drugs and other xenobiotics. The use of microorganisms as in vitro models to mimic and predict mammalian biotransformations for initial metabolism studies has many advantages including the ability to produce large quantities of metabolites for full structural characterization and biological evaluation, substantially reduced cost over in vivo studies, and lessened animal demand. Befulinic acid, a pentacyclic lupane-type triterpene, is a relatively common natural product that was recently reported as a melanoma-specific cytotoxic agent following both in vitro and in vivo studies. Because of its high antitumor activity and lack of toxicity, the drug is currently undergoing preclinical development for the treatment or prevention of malignant melanoma. An essential part of preclinical development of a drug is to elucidate its mammalian biotransformations and evaluate the biological activity and/or toxicity of its mammalian metabolites. Since there have been no reports on the mammalian metabolism of betulinic acid, it is the main objective of this study to utilize microbial cultures as model systems to predict and prepare potential mammalian metabolites of betulinic acid. In addition, the generated metabolites of betulinic acid will be evaluated for antitumor activity and/or toxicity.